MOLECULAR MODELING OF OLIGO-DNA

Molecular modeling of various conformations of oligo-DNA double- and triple-stranded segments has been performed, in order to gain insight into the possibility of residues from a third strand in the vicinity of a double helix. This technique provides a tool for studying the possibility of structural enhancement, or the blocking of it, from certain nucleic acid analogues to the formation of triple helices. This tool, in turn, aids the design of synthetic drugs.